Application of SHP2 PROTAC to Mitigate Articular Cartilage Degeneration

PROJECT SUMMARY:
It has been known for years that somatic SHP2 deletion in chondroid cells causes cartilage tumor
formation associated with elevated SOX9 expression. However, it remains incompletely understood
mechanistically how SHP2 depletion increases SOX9 and promotes chondroid cell proliferation. The work
outlined in this proposal builds on our novel discovery that the genetic deletion of SHP2 in cartilage cells
increases SOX9 abundance associated with SOX9 phosphorylation and sumoylation. These findings together
stimulate the hypothesis that SHP2 physiologically limits SOX9 level in cartilage via posttranslational
modifications. Therefore, intraarticular SHP2 depletion increases SOX9 protein abundance and transcriptional
activity, promoting chondrocyte anabolism and protecting AC from injury-evoked degeneration. To test this
novel hypothesis, we proposed two specific Aims. In Aim #1 we will determine to what extent intraarticular
SHP2 degradation, using the first SHP2 PROTAC drug SHP2D26, mitigates injury-evoked articular cartilage
degeneration. In Aim #2, we will interrogate the molecular mechanism through which SHP2 depletion
enhances SOX9 abundance by focusing on SHP2’s regulation of SOX9 posttranslational modifications. This
innovative study will result in the first-ever description of the mechanisms by which SHP2 modulates cartilage
anabolism through SOX9 and provide instrumental information on the translational application of SHP2D26 in
countering cartilage degeneration. Successful completion of the work proposed will have a significant impact
on cartilage biology and OA prevention.

Public health relevance
PROJECT NARRATIVE: This proposal builds on our novel discovery that depletion of the enzyme SHP2 in cartilage cells increases the abundance and transcriptional activity of SOX9, one of the master chondrogenic transcription factors in cartilage. Using the cutting-edge proteolysis targeting chimera (PROTAC) and articular cartilage-specific fluorescent reporter mice, we will interrogate the mechanism by which SHP2 modulates SOX9 abundance and transcriptional activity, and to what extent SHP2 degradation with the first SHP2 PROTAC drug, SHP2D26, protects articular cartilage from injury-evoked degeneration. The outcome of this work will yield groundbreaking information regarding SHP2’s role in articular cartilage homeostasis and the translational application of SHP2D26 for articular cartilage anti-degeneration and regeneration.